MARC at the University of California, Davis

The mission of the UC Davis MARC program is to increase the diversity of students who complete their
baccalaureate degree and subsequently pursue a PhD, MD/PhD, or DVM/PhD in a biomedical research-focused
STEM field. To achieve our overarching goal, we have expanded and improved upon our current MARC award
and have developed a comprehensive research-focused training program to encourage students from groups
underrepresented in the biomedical sciences to pursue research careers. Our MARC program will develop
trainee science identity and science community values, and will enhance the interests, knowledge, and
foundational skills required for successful matriculation into biomedical PhD programs. We propose to appoint
14 students annually to participate in a two-to-three-year MARC training program, which will include at least two
summers of full-time research and two academic years of part-time research, complemented by professional
development activities, advising, and community and mentoring activities to enhance the social and scientific
identity of participants. We will deeply engage students in research with quality faculty mentors and will develop
in trainees a broad set of research-related skills through extensive discussions of biomedical research topics,
including research integrity and reproducibility, as well as experimental design. The program will provide trainees
with guidance and experiences in delivering scientific presentations and developing proposals, and offer career
information and support in the graduate school application process. Additionally, program activities will promote
student retention and academic excellence through activities designed to foster social and academic integration
within a supportive peer group environment. The following specific objectives support our overall goal. MARC
students will: (1) Learn the importance of conducting biomedical research responsibly, ethically, and with
integrity; (2) Increase their scientific expertise with respect to understanding scientific reasoning, rigorous
experimental design, data analysis, and interpretation; (3) Develop science communication skills by presenting
their research locally and nationally at conferences such as ABRCMS (Annual Biomedical Research Conference
for Minoritized Scientists), SACNAS (Society for Advancement of Chicanos/Hispanics and Native Americans in
Science), and/or discipline-specific meetings; (4) Develop a science identity and sense of belonging within the
scientific community; (5) Develop a professional network that includes supportive mentors at a variety of career
stages; (6) Have the opportunity to engage in outreach activities to diverse first- and second year EEOP
students; (7) Learn about the features of a competitive graduate school application; (8) Maintain/enhance their
commitment to careers in biomedical research; (9) Graduate at a percentage of 90% with a GPA that is
competitive for entrance into a PhD program; (10) Enter PhD or MD/PhD or DVM/PhD programs in biomedical
related disciplines within 3 years of graduation at a rate of at least 70%.

Public health relevance
Narrative Our MARC program aims to increase the diversity of students pursuing a PhD in a STEM field and a research career in the biomedical sciences. To achieve this goal, we have developed a series of activities for underrepresented, disadvantaged, and disabled undergraduates. These activities are designed to facilitate the development of their talent and professional skills in preparation for excelling in their subsequent PhD (or MD/PhD or DVM/PhD) programs and careers in biomedical science.